Handheld Spatial Frequency Domain Imaging (SFDI) to measure skin involvement in Scleroderma

PROJECT SUMMARY
Scleroderma, or systemic sclerosis (SSc) is a chronic, autoimmune disorder, characterized by skin and internal
organ fibrosis. There are no uniformly effective therapies for SSc, which suffers from the highest mortality of all
autoimmune diseases, with a 10-year survival rate of 62-65%. Early diagnosis enables timely intervention,
potentially preventing internal organ damage and improving survival. The extent and progression of skin
involvement is a predictor for future organ complications and survival. Accurately assessing the degree of skin
thickening in patients with SSc is thus of vital importance, and one of the primary outcome measures in SSc
clinical trials. The current clinical standard of scleroderma skin assessment is the modified Rodnan Skin Score
(mRSS). mRSS is an integer score between 0-3, assigned to different regions of the body based on subjective
assessment of skin thickening by clinical palpation. mRSS is an unreliable metric, with intrinsic technical
challenges such as a poor inter-observer variability and uncertainty regarding its sensitivity to longitudinal
changes. There is a need for a reliable, objective and quantitative metric to assess skin involvement in
scleroderma. In this project, Spatial Frequency Domain Imaging (SFDI), a non-invasive, wide-field diffuse
optical imaging technique is proposed as an objective, repeatable and quantitative alternate to mRSS. SFDI
uses near infrared light to generate widefield images of tissue optical properties (diffuse reflectance (Rd),
absorption (µa) and reduced scattering coefficients (μs′)) at subsurface depths. Preliminary clinical data shows
that μs′ and Rd can differentiate between patient and control groups, correlate well with mRSS, and detect sub-
clinical changes in early SSc. To advance SFDI towards a usable research and clinical device for SSc,
this project aims to build a handheld SFDI device and validate its use for SSc skin assessment. For clinical
translation, this device will need to reliably measure all regions of the body quickly and provide real-time
information to the clinician. Using a new innovation developed in our lab that employs a rotating spiral pattern
for SFDI to measure both optical properties and scattering anisotropy, a simplified, hand-held clinical device
will be developed. Next, a processing pipeline will be developed, which will provide a real time SSc “score” to
the clinical provider. Finally, the device will be validated on a cohort of SSc patients and controls. This project
aims to develop an easy-to-use and scalable device that would improve clinicians’ ability to monitor
SSc, develop treatment plans, and could be used for multi-site clinical studies for SSc and other skin
diseases.

Public health relevance
PROJECT NARRATIVE Currently, there is no reliable, objective method to assess skin involvement in Scleroderma, a chronic, autoimmune disorder characterized by skin and internal organ fibrosis. Preliminary data indicates that Spatial Frequency Domain Imaging (SFDI), a diffuse optical imaging technique, may provide a new method to measure the extent of skin involvement in the disease. Clinical translation of SFDI for Scleroderma assessment will be possible with a handheld SFDI device, which would improve clinicians’ ability to track disease progression, patients’ response to therapies, and could be utilized in multi-site clinical studies for disease treatments.